Transformative microscopes to image across spatiotemporal scales

Project abstract
How molecular organization and activity leads to tissue level outcomes is an open
question in biology and biomedical research. Addressing this question is technically
challenging because we cannot observe with molecular precision at the tissue scale.
While optical microscopy is the method of choice to observe architecture and dynamics
within living cells and organisms, it has severe limitations in spatiotemporal resolution and
volumetric coverage. Thus, our most detailed observations of cellular dynamics and
ultrastructure have been limited to single cells on coverslips, which were far removed from
their physiological context.
Here I propose to extend the capabilities of light-sheet fluorescence microscopy (LSFM),
a technology that provides gentle and efficient 3D imaging, but only moderate resolution.
We will combine LSFM with super-resolution methods to allow rapid imaging of
subcellular dynamics away from coverslips. We will further explore ways to increase the
volumetric acquisition rate of LSFM such that large samples can be rapidly explored.
These new developments will be tied together by smart sampling strategies, which will
enable autonomous exploration of large samples while applying the highest resolution
only locally. This way, we expect that rare cellular events can be studied in subcellular
detail in entire model organisms or organs that were rendered transparent through
clearing. The proposed rapid volumetric imaging capabilities will enable imaging of all
neurons in a small model organism such as C.elegans or Zebrafish embryos with up to
100 Hz volume rate. Such rapid pan-neuronal imaging may shed light on how a brain
functions. While we expect that the potential for discovery with such microscope
technology is immense, access to such advanced instrumentation is often limited. To
address this, we will develop a modular light-sheet platform that can be adapted to a wide
range of imaging tasks. We will further explore ways to simplify the microscope
architecture and design less expensive variants to aid dissemination.
The resulting new microscope technology will enable large volume imaging experiments
that have been prohibited by either lack of spatial resolution or acquisition speed, and as
such accelerate biological and biomedical research.

Public health relevance
Project Narrative My proposed research program will provide technologies to extend the reach of optical microscopy, from subcellular dynamics up to entire model organisms. At the same time, we will bridge these different scales through smart microscopy, which autonomously adjusts temporal and spatial resolution to efficiently (in terms of time, amount of data and sample irradiation) explore a specimen. If successful, these technologies may prove transformative in biological and biomedical research.